American Head and Neck International Conference

Project Summary/Abstract
The 11th International Conference on Head and Neck Cancer to be held July 8-12, 2023, in Montreal, Canada,
is designed to facilitate discussion among practitioners, trainees, and researchers with an emphasis on how
collaborative, multidisciplinary treatment and rehabilitation can lead to the best oncologic, functional, and
quality of life outcomes for head and neck cancer patients. The American Head and Neck Society sponsors
this meeting, which occurs every three years and attracts well over 1500 attendees representing the disciplines
of medical oncology, radiation oncology, radiology, and head and neck surgery, to ensure educational
interactions within and between specialties that can strengthen multidisciplinary collaborative relationships.
Objectives for the meeting include i) to further understanding and to identify gaps in our understanding of head
and neck cancer care, and foster research in those areas within and between the multiple disciplines
represented; ii) to recognize the important role of nurses, speech pathologists, audiologists, nutritionists, social
workers, pain specialists, mental health practitioners, physical therapists, and dental oncologists in achieving
maximal functional outcomes, and in proper functional assessment and reporting of functional results of new
treatment programs; and iii) to provide familiarity with emerging research breakthroughs that are helping us to
better understand the pathogenesis and treatment of head and neck cancer. Funds are requested in this
application in order to improve access to the conference for trainees and young families through
(1) Trainee travel awards for students, residents, clinical fellows, and postdoctoral fellows, with a particular
focus on supporting underrepresented minority attendees, and (2) Providing childcare at the meeting to
reduce barriers to attendance for working parents. This support will enhance conference participation by
diverse groups of trainees, clinicians, and researchers, giving them the opportunity to present their research,
develop collaborations, and interact with experts in the field.

Public health relevance
Project Narrative The International Conference on Head and Neck Cancer is the most important international, interdisciplinary conference in the field of head and neck oncology, with 1500 to 2000 attendees. The 11th International Conference on Head and Neck Cancer will be held in July 2023 and is designed to facilitate discussion among practitioners, trainees, and researchers with an emphasis on how collaborative, multidisciplinary treatment and rehabilitation can lead to the best oncologic, functional, and quality of life outcomes for head and neck cancer patients. This application requests funds to improve access to the conference by (1) supporting travel expenses for students and trainees – the next generation of researchers and clinicians in head and neck oncology – with a particular focus on supporting underrepresented minorities, and (2) providing childcare during the meeting to enable parents with young children to participate in the conference.